Calcium-mediated paracrine signaling in beta cell cilia

Project Summary/Abstract
This proposal presents a five-year research career development program to prepare the principal investigator
(PI) Samantha Adamson, M.D., Ph.D., to become an independent physician-scientist in the field of diabetes
research. The PI obtained PhD training in metabolic research at the University of Virginia with Dr. Norbert
Leitinger and completed clinical training in Internal Medicine and Endocrinology at Washington University in St.
Louis. The PI is currently an Instructor in Medicine and post-doctoral researcher in the lab of Dr. Jing Hughes
at Washington University, studying the role of primary cilia in the function and crosstalk of pancreatic islet cells.
Dr. Jing Hughes, Assistant Professor of Endocrinology at Washington University, will mentor the PI with Dr.
David Piston, Chair of Cell Biology and Physiology, as co-mentor. Dr. Hughes is an emerging leader in islet
and cilia research with R01 funding and is a Gateway Investigator of the Human Islet Research Network. Her
expertise spans from immunology to adipocyte biology to islet cell biology, currently focusing on intra-islet cell
communication via primary cilia. Dr. Hughes is a respected mentor of students, postdocs, and fellows both in
the lab and in clinics. She serves as a perfect example of a successful physician-scientist who asks
fundamental questions in cell biology that are grounded in clinical perspective. Dr. Piston has 30 years of
research experience elucidating the molecular mechanisms that underlie hormone secretion from islets. He
has mentored 37 undergraduate and graduate students, 20 post-docs, and 3 K-award fellows.
The PI will take advantage of this mentorship, an expert advisory committee, and the rich and diverse scientific
resources available at Washington University to define a new area of mechanism-based research in diabetes.
Precise control of hormone secretion from islet cells is crucial for glucose homeostasis. Primary cilia mediate
paracrine communication in islets by virtue of ciliary enrichment of somatostatin receptor 3 to control
somatostatin signaling to beta cells. Preliminary data show the protein TULP3 is responsible for trafficking of
somatostatin receptor to cilia and that the calcium channel polycystin 2 is required for proper calcium signaling
in beta cells, an important second messenger. The research goal of this proposal is to define the mechanisms
of ciliary somatostatin-mediated paracrine signaling through three focused aims. To accomplish these goals,
the PI will define the role of TULP3 in trafficking of somatostatin receptor to beta cell cilia by deleting TULP3 in
islets and assessing ciliary receptor localization, intracellular calcium signaling and insulin secretion in
response to somatostatin compared to control islets. Further studies will focus on understanding the
contributions of calcium signaling occurring in the cilia versus the cell cytosol in response to somatostatin and
the role of the ciliary calcium channel polycystin. These studies will provide new insights in the pathogenesis of
beta cell failure and potentially lead to the development of cilia-targeted therapy to potentiate insulin secretion
for individuals living with diabetes.

Public health relevance
Project Narrative Diabetes results from an imbalance between insulin secretion and metabolic demand. Our research aims to identify novel, primary cilia-based calcium signaling mechanisms that underlie islet cell crosstalk and are important for regulating insulin secretion, in order to generate more effective therapies that preserve beta cell function in human diabetes.